Optimized methods for measuring brain excitability in depression

PROJECT SUMMARY
Repetitive transcranial magnetic stimulation (rTMS) is an effective treatment for depression, but clinical
responses are highly variable. This is because the underlying neural mechanisms, as well as the optimal
treatment parameters, remain unclear. Treatment targeting the dorsolateral prefrontal cortex (dlPFC) aims to
improve symptoms by restoring impaired prefrontal excitability. However, evidence of impaired excitability in
depression and subsequent neural change after rTMS is limited due to the lack of reliable markers of prefrontal
excitability that can be measured and tracked during rTMS. There is an urgent need for reliable markers of
prefrontal excitability to direct personalized treatment and guide systematic screening of novel protocols.
Our long-term goal is to improve depression treatment by establishing reliable markers of prefrontal
excitability. We hypothesize that biologically-grounded TMS parameter adjustments can optimize prefrontal
excitability measurements to effectively capture alterations in depression and modulation following rTMS. The
early local TMS-evoked potential (EL-TEP) is a short-latency response recorded over the dlPFC stimulation site
that has been shown to be altered in depression and correlate with treatment outcome, but has suffered from
low signal-to-noise and reliability issues. We recently developed TARGET (Targeting with Automated Real-time
Guidance for Enhancing TEPs) to enhance EL-TEPs by dynamically adjusting TMS parameters, increasing EL-
TEP signal-to-noise three-fold and reliability two-fold. However, TARGET's lengthy optimization time, lack of full
automation, unclear neural impact, and uncharacterized alteration in depression limit its current utility.
We will 1) investigate how adjusting TMS parameters affects neural activity measured with intracranial EEG, 2)
optimize TARGET and study EL-TEPs in depression, and 3) test how optimized EL-TEPs detect changes in
prefrontal excitability induced by cognitive tasks and rTMS.
Impact: This research will characterize TMS parameter effects on neural responses and develop efficient
methods for cortical excitability assessment. Success will enhance brain-based monitoring and facilitate novel
personalized treatments guided by cortical excitability. Future work will apply this approach to obtain reliable
noninvasive measures of cortical excitability across various brain regions and disorders. This work will lay the
foundation for clinical trials using TARGET-optimized EL-TEPs as surrogate endpoints for rapid evaluation of
treatment effects.

Public health relevance
PROJECT NARRATIVE Repetitive transcranial magnetic stimulation (rTMS) shows promise for treatment-resistant depression, but its therapeutic effects are inconsistent due to an inability to reliably measure and optimize its impact on brain excitability. This research develops TARGET, a novel technique that enhances noninvasive measurements of prefrontal cortex excitability. By utilizing TARGET to characterize brain differences in depression and track changes during rTMS, we aim to personalize rTMS treatments and facilitate rapid development of new stimulation protocols, ultimately improving outcomes for the millions suffering from this debilitating condition.